Biosynthesis of Marine Polyketide Antibiotics

Project Summary / Abstract The emergence of antibiotic resistance has created a global dilemma for the need to discover new antibacterial lead agents. As the majority of antibiotics are derived from nature, and in particular from terrestrial soil bacteria, in recent years marine bacteria have been established as promising sources of antibacterial compounds. An underlying theme associated with many marine microbial antibiotics involves the use of aromatic polyketide frameworks that have undergone extensive oxidative tailoring reactions catalyzed by halogenase and oxygenase biosynthetic enzymes. In this application, we propose a multidisciplinary project involving heterologous biosynthesis, mechanistic enzymology, atomic resolution protein X-­ray crystallography, chemoenzymatic synthesis, and genetic engineering to understand the molecular basis of polyketide diversification in a series of marine bacterial antibacterial agents with promising biological properties. To accomplish the broad goals outlined in this application, we propose four specific aims. First, we plan to functionally and structurally characterize diverse meroterpenoid V-­dependent chloroperoxidases and their catalytic properties in promoting antimicrobial chemical diversity. Second, we will discover, characterize, and engineer biosynthetic pathways for structural diversification of halogenated pyrrole containing bioactive natural products. Third, we aim to functionally characterize the biosynthesis of the thiolactomycin polyketide antibiotics and their novel sulfur insertion enzymology. And fourth, we will functionally characterize the salinamide ether bridge forming enzymes and design new derivatives for biological evaluation.

Public health relevance
Public Health Relevance Statement The majority of clinically used antibiotics are derived from nature, and of those, most are produced by related soil bacteria. Realizing the critical need for new antibiotics to combat increasing bacterial resistance to known antibiotic drugs, antibacterial agents from marine microbes are emerging as promising drug leads due to their distinctive chemical structures. This application investigates novel biosynthetic enzymes that construct and diversify polyketide antibiotics from underexplored marine bacteria. Anticipated outcomes of this research project will be the discovery of new biosynthetic reactions in natural product diversification and the application of this basic knowledge to the (chemoenzymatic) synthesis and bioengineering of designer agents for biological evaluation in antibacterial screens.